Cortical circuit mechanisms of sensorimotor object localization

PROJECT SUMMARY
How sensory and motor signals are integrated in the brain to produce perception of object location remains
poorly understood. Primary somatosensory cortex (S1) is a candidate site for sensorimotor integration that
underlies object localization. Mouse S1 is a powerful system in which to uncover general principles and
specific circuit implementations of sensorimotor integration that shape perception of object location. Revealing
these will provide fundamental knowledge of healthy cortex function from which processing disruptions from
stroke, spinal injury, and other neurological disorders may be more fully understood.
The long-term goal of this work is to understand cellular and circuit mechanisms underlying tactile
perception. This proposal focuses on how S1 integrates sensory and motor signals during active touch
behaviors. Head-fixed mice can determine the angular position of objects by active exploration with a single
whisker. Sophisticated neural processing underlies this simple behavior, which makes it an excellent model
system for dissecting circuit mechanisms of somatosensory integration. Several competing models exist for
how the brain solves this task. They differ in the type, origin, and integration location of sensorimotor signals
used. Distinguishing between these models is critical for understanding the role internal motor signals in
cortical circuits play in construction of tactile perception. Prior studies failed to do so because of limitations in
task design and quantification of behavioral variation. This proposal overcomes these limitations with
innovative approaches that include an improved localization task, high-speed sensorimotor tracking, cell type-
specific electrophysiology, calcium imaging, sophisticated decoding models, and closed-loop optogenetics.
The overall objective of this proposal is to distinguish between sensorimotor integration models by
quantifying behavior, identifying candidate codes for object location in S1, how these are constructed, and their
influence on perception. Our central hypothesis is that object location is encoded by the set of excitatory
neurons activated by touch in L5B of S1, and that object location tuning in L5B cells requires both thalamic
input and motion-subtracted touch signals from L4 of S1. We further hypothesize that M1 input amplifies L5B
activity without affecting object location tuning. This hypothesis is supported by our preliminary data including
cell-type and layer-specific recordings in S1 and optogenetic circuit manipulation during object localization. The
hypothesis will be tested by pursuing three Specific Aims. 1) Identify candidate codes for object location in S1
neurons. 2) Identify the origin of signals contributing to object location tuning in S1 neurons. 3) Test object
localization models with closed-loop optogenetic manipulation of S1 circuits. The contribution of the proposed
research will be significant because it will generate detailed knowledge about the neural dynamics in S1 that
underlie touch perception, uncover general principles of sensorimotor integration and specific cortical circuit
implementations of that integration during behavior, and package it all into a publically accessible resource.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will produce fundamental knowledge of how patterns of neural activity in cortex generate tactile perception in a mouse model system. This is relevant to NIH’s mission because this knowledge is needed to understand sensorimotor processing disorders, which could reduce the impact of disabilities in millions of Americans living with stroke, spinal injury, and other neurological impairments.